Heterogeneity in bacterial quorum sensing during infection

Summary
This supplement application is to acquire a -80°C freezer that will facilitate the storage of bacterial and animal
tissue stocks. Addressing the specific aims of the parent R01 project has led to the -80°C freezer currently
available for frozen stocks reaching its storage capacity. The ability to generate and store additional samples
at -80°C is critical to the parent project.

Public health relevance
PROJECT NARRATIVE Insight into the changes in bacterial physiology that promote host colonization will be sought through studies of the natural symbiosis established between a squid and bacterium Vibrio fischeri. V. fischeri uses intercellular communication to regulate physiological traits important for host colonization, which makes this symbiosis a unique opportunity for investigating how these signaling systems function during the infection process. Because human health is linked to the proper assembly of beneficial microbes, these studies will improve human health by increasing our understanding of how bacterial signaling systems promote the acquisition of beneficial microbes.